Cellular and molecular characterization of the digestive tract sub-epithelium

Project Description
Epithelial development, integrity, and turnover in the digestive tract depend on signals from adjacent
mesenchymal cells, and defective signaling may underlie aspects of disorders such as Inflammatory Bowel
Disease, pathologic response to infection, malabsorption, and cancer. Crucial mesenchymal signals
include Wnt factors and bone morphogenetic protein (BMP) agonists and antagonists, and recent research
implicates various (CD34+, Foxl1+, PDGFRA+, Gli1+) cell types as possible sources. However, the precise
identities, overlap, and requirements of these populations remain unclear. Integrated consideration of high-
resolution microscopic anatomy, molecular profiling of diverse marker-defined cells, and single-cell RNA
analysis has led us to identify 3 distinct mesenchymal cell types in the mouse small intestine. Cells
expressing high platelet-derived growth factor receptor A (PDGFRAhi) lie closest to the epithelium and
correspond to recently described Foxl1+ telocytes. These cells express abundant BMPs and congregate
particularly at the crypt-villus junction, whereas two PDGFRAlo cell populations are anatomically and
molecularly distinct: those located near the crypt stem-cell zone that uniquely co-express PDGFRA,
tetraspanin CD81, and the BMP antagonist Gremlin1, and cells in the villus lamina propria that lack surface
CD81. These data collectively suggest the novel hypothesis that crucial crypt-villus BMP gradients reflect
dense sources of agonists at the villus base and antagonists at the crypt base. Specific Aim 1 will test this
hypothesis and further resolve the distinctive features and functions of mesenchymal PDGFRAhi and
PDGFRAlo cells in the mouse small intestine. Building on preliminary data that unfractionated PDGFRAlo
cells support expansion of ISCs in vitro, we will investigate the possibly opposing functions of pericryptal
CD81+ and villus CD81- subpopulations. In response to ISC damage, the mesenchyme triggers crypt
progenitors to dedifferentiate, likely through the same soluble factors that maintain uninjured ISC. Aim 2
proposes a systematic, unbiased approach to identify the specific cellular sources of key restitutional
signals. We will also test the hypothesis that mesenchymal PDGFRAhi and PDGFRAlo cells depend on the
intestinal epithelium to provide varying concentrations of the ligand PDGFA for their survival, proliferation,
and distinct physiologic functions. ISC and crypt progenitors have counterparts in the stomach epithelium,
which turns over more slowly, depends less on Wnt signaling, and does not extend villi. Mesenchymal
PDGFRA+ cells are equally abundant in both organs, with likely important similarities and differences in
organization and functions. To better understand gastric stem/progenitor cell control and the underlying
signaling logic in both organs, Aim 3 will characterize stomach mesenchymal PDGFRA+ cells in the same
depth that we have achieved in the intestine. Together, these studies apply innovative experimental
approaches to examine specific hypotheses that address fundamental questions in digestive tract biology.

Public health relevance
Project Narrative: Continuous and necessary self-renewal of the cells that line our intestines and stomachs depends on signals from adjacent `sub-epithelial' cells. Our precise anatomic and molecular characterization of this `sub-epithelium' reveals distinct cell populations that serve crucial signaling and supportive functions. The studies we propose will advance understanding of these cells and signals, and hence improve the ability to accelerate healing of epithelial damage (ulcers) and to treat bowel inflammatory disorders.